Tumor susceptibility gene 101, a new microglial therapy candidate for Alzheimer’s disease to prevent cognitive decline

PROJECT SUMMARY/ABSTRACT
There is an urgent need for developing the cure for Alzheimer’s disease (AD), which is predicted to affect 139
million people in the world by 2050. Emerging evidence have shown that brain innate immune cells, microglia,
are critically involved in the progression of neurodegeneration while they take important roles in clearing
aggregated protein such as amyloid β plaque or phosphorylated tau(p-tau). We have recently uncovered the
mechanism of tau propagation in AD mediated by increased extracellular vesicles (EVs) containing p-tau
secreted from plaque associated microglia in APP KI mouse model. In this application, we aimed for targeting
tumor susceptibility gene 101, Tsg101, one of endosomal sorting complexes required for transport (ESCRT)-I,
critically regulating the EV synthesis in microglia to manipulate EV secretion and mitigate tau pathology
development in PS19 tauopathy mouse. Our exciting preliminary data have shown that conditionally knocking
out microglial TSG101 in PS19 tauopathy mice significantly improved cognitive functions at 7 months of age,
reduced tau pathology and prevented synaptic loss in the hippocampal field. Furthermore, RNA hippocampal
tissue bulk RNA sequence results indicated that ablating microglial Tsg101 reduced hippocampal
neuroinflammation, complement pathway and microglial neurodegenerative phenotype signature genes,
suggesting that microglial Tsg101 is critically involved in immune regulation.
We will validate our preliminary results and further investigate the role of Tsg101 on microglial activation and/or
AD pathology with three experimental paradigms. i) targeting Tsg101 in microglia of AD animal models, ii)
targeting TSG101 in human microglia in vitro iii) targeting TSG101 in human microglia reconstituted in AD animal
models in vivo. The successful completion of this study will validate Tsg101 as a novel therapeutic target of
microglia for the suppression of their EV secretion, tau propagation and synaptic pruning via complement
pathway and give fundamental knowledge for targeting microglial molecules as AD therapeutics.

Public health relevance
PROJECT NARRATIVE We will examine the therapeutic efficacy of targeting microglial molecule for generation of extracellular vesicles on suppression of tau accumulation, a pathological hallmark of Alzheimer’s disease (AD), and neuroinflammation. This gene targeting will be examined in animal models of AD and human microglial like cells derived from induced pluripotent stem cells in vitro and in vivo using AD mouse models reconstituted with human microglia. The successful completion of the study will lead to the development of microglia-targeted therapy of AD.